Investigating the role of retinal astrocytes in exercise-induced retinal neuroprotection

Photoreceptor dysfunction is one of the hallmark pathologies associated with retinal degenerative (RD)
diseases that manifests in patients as a progressive loss of vision. This encompasses heterogenous diseases
such as retinitis pigmentosa, which affects 1 in 3500 people worldwide and age-related macular degeneration,
which affects over 196 million people worldwide and is projected to reach 288 million people by 2040.
Specifically, in our Veteran population, roughly 7,000 Veterans become visually impaired each year due to RD.
Clinical trials and retrospective studies suggest that RD patients may respond to exercise as a neuroprotective
treatment to preserve vision. Recently, our labs filled a significant knowledge gap by demonstrating that
modest exercise protects retinal function and structure in models of RD and were accompanied by increased
levels of brain derived neurotrophic factor (BDNF) and required intact BDNF-TrkB signal transduction. To date,
the cell-types and molecular processes mediating the neuroprotective benefits of exercise are unknown.
Others have shown that astrocytes and endothelial cells in the brain express BDNF and its high-affinity
receptor, TrkB, and that altered BDNF-TrkB signaling in these cell-types contributes to neurodegenerative
disease progression and severity. Recently, it has been demonstrated that astrocytes modify their morphology
in response to BDNF in the brain during neurodegeneration. Likewise, vascular endothelial cells express BDNF
under exercise-induced physiological stress. These data suggest that astrocytes and endothelial cells may
mediate the neuroprotective effects of exercise in the retina. Our approach is to understand the morphological,
gene expression and functional alterations in retinal astrocytes and vasculature induced from exercise and how
these alterations contribute to neuroprotection. For this proposal, we will use the BALB/c light induced retinal
degeneration model, which exhibits phenotypes found in patients with RD. We hypothesize that exercise
induces retinal astrocyte plasticity and improved vascular function through increased BDNF signaling
mechanisms, promoting neural repair and protection. In Specific Aim 1, we will investigate if exercise
influences retinal astrocyte biology, by assessing retinal astrocyte morphology, cellular gene expression
profiles, and retinal astrocyte-mediated phagocytosis. Immunohistochemical labeling, AnalyzeSkeleton and
Sholl analysis will be used to quantify astrocyte cell morphology and density. Retinal astrocytes will be isolated
using magnetic-activated cell sorting (MACS) to examine astrocyte gene expression profiles. To monitor retinal
astrocyte function, a novel in vitro live-imaging of astrocyte-mediated phagocytosis will be used. In Specific
Aim 2, we will determine the effects of exercise on retinal vascular morphology, gene expression and function.
Angiotool will be used for retinal vascular morphology quantification analysis. Retinal vascular cell gene
expression profiles will be assessed by MACS and vascular function will be assessed using retinal functional
hyperemia. In Specific Aim 3, we will determine if exercise-induced BDNF signaling mechanisms influence
retinal astrocyte and vascular morphology, gene expression and function, by blocking BDNF signaling using a
highly specific TrkB receptor antagonist, ANA-12. Retinal astrocyte and vascular assessments performed in
Specific Aims 1 and 2 found to be most informative will be used to compare experimental groups. The
expected outcome of this study is that exercise-induced BDNF signaling alters retinal astrocyte and vascular
morphology, gene expression and improves function in order to promote retinal neuroprotection. Results from
this study will illuminate the morphological, gene expression and functional alterations that ultimately result in
gain of function(s) and or loss/upregulation of homeostatic function(s) in retinal astrocytes and vasculature.
This proposal holds profound potential for the long-term goals of optimizing exercise-based therapeutics and
creating new pharmacological strategies targeting the underlying mechanisms of exercise-induced protection
in patients with RD that can be extended to other neurodegenerative and neuroinflammatory diseases.

Public health relevance
Photoreceptor dysfunction is one of the hallmark pathologies associated with retinal degenerative (RD) diseases that manifests in patients as a progressive loss of vision. This encompasses heterogenous diseases such as retinitis pigmentosa, which affects 1 in 3500 people worldwide and age-related macular degeneration, which is projected to affect 288 million people by 2040. We have shown modest exercise provides retinal neuroprotection in a mouse model of RD, through increased brain derived neurotrophic factor (BDNF) signaling. The cellular modifications provoking neural protection and repair from exercise are not understood. Our proposal reveals novel data supporting retinal astrocyte and vasculature involvement in exercise-induced BDNF signaling. Our studies will illuminate the roles of retinal astrocytes and vasculature in this known neuroprotective therapy, ultimately optimizing exercise-based therapeutics and creating new pharmacological strategies targeting the underlying mechanisms of exercise-induced neuroprotection.